Data Management and Analysis Core

ABSTRACT
The Data Management and Analysis Core (DMAC) is designed to provide a shared resource for data
management and analysis across projects, and to facilitate the integration and sharing of data and analytic
resources. By centralizing these activities, we will ensure the integrity of the data produced by each project,
create efficiencies through sharing of data and analytic resources, and provide biostatistical consultation that
incorporates an in-depth knowledge of pulmonary fibrosis etiology. This strategy will also allow us to coordinate
study design and data management issues, leading to a more coherent approach to data analysis, as well as
significant cost savings The Core Lead (Peljto) will supervise a team that is experienced in the conduct of studies
involving multidisciplinary research. The team also has the skill set required to manage complex issues of study
design, multifaceted database management, genomics, and broad quantitative methods. The key activities of
the DMAC will be 1) providing study design consultation and refinement, 2) providing a secure, central repository
and quality control for data generated, 3) conducting biostatistical and bioinformatics analyses to test proposed
hypotheses 4) facilitating integration and sharing of Project data and analytic resources. These activities will
directly serve all four projects through study design consultation and analysis. In addition, the DMAC will work
closely with Cores B and C to transfer, annotate, and store data and digital images generated for each Project.
Finally, this Core will coordinate with the Administrative Core, as it provides the administrative and organizational
structure to support this Program, and will receive direction from the Administrative Core. This Core will interact
with the Administrative Core and Project Investigators at regular meetings, such that each week Dr. Peljto and
appropriate DMAC members will meet with either an individual Project team or the entire Program. These
activities of the Core will assist all of the Projects and the Administrative Core in fulfilling their research, reporting,
and resource sharing goals and obligations